The Patient-Reported Outcomes, Community-Engagement and Language (PRO-CEL) Core

ABSTRACT
The Patient-Reported Outcomes, Community Engagement, and Language (PRO-CEL) Core enhances
the objectives of the Center's research programs by supporting the array of MSK investigators who wish to
capture self-reported information from culturally diverse patients, caregivers, clinical staff, and community
members. The faculty of the PRO-CEL Core are nationally recognized social, behavioral sciences, and
community-engagement experts who provide technical assistance to all users throughout their various stages
of research, including grant and protocol development, research study assistant and support staff training, and
result dissemination. The PRO-CEL Core aims to 1) provide expert consultation with respect to selection,
analysis, and interpretation of psychometrically sound patient-reported outcomes (PROs) or other self-report
instruments for the capture of health-related quality of life (HRQoL), health behavior change, symptom control,
treatment-related adverse events (AEs), and quality of care; 2) support qualitative interview, focus group, and
other observational research methodology for generating new testable hypotheses, developing novel
assessment tools, and establishing cultural and linguistic equivalency of PRO measures; 3) provide pre-review
and feedback of peer-reviewed funding applications consistent with “best practices” in psychosocial,
behavioral, and community-engaged oncology research, including culturally and linguistically responsive
research; 4) assist with the creation of online surveys for data capture; and 5) provide methodological support
for clinical trial, behavioral, and population-based research that seeks to engage community or minority
populations. The services provided by the PRO-CEL Core have supported the research of 105 MSK
investigators in the past year, and during the past grant period, the work of this Core has contributed to 397
peer-reviewed publications.